Using Mixed Methods to Examine the Risk and Protective Factors of Suicide Among Justice-Involved Black

PROJECT SUMMARY/ABSTRACT
Suicide and suicide thoughts and behaviors (STBs) increased at alarming rates among Black youth over the last
decade, faster than any other racial/ethnic group. Suicide is now the third leading cause for Black youth. As
highlighted in RFA-MH-22-141, there is an urgent need to identify risk and protective factors for suicide and
STBs among Black youth, which in turn can inform the development of prevention and intervention approaches.
The proposed research directly addresses that need by examining theoretically- and culturally informed risk and
protective factors for STBs in an especially vulnerable group: justice-involved Black youth (JIBY). Rates of
suicide and STBs are particularly high among JIBY, exceeding rates among the general population. Studies
examining JIBY experiences in family, school, community, and juvenile justice are rare, in part because justice-
involved are a hard-to-reach population; youth in custody are poorly represented in school-administered national
youth survey data intended to collect data for the general population. Further, prior research on STBs among
Black youth has been driven largely by Eurocentric or race-neutral perspectives and an emphasis on single risk
factors rather than a concentration of risk factors that JIBY often experience.We propose to leverage 11-years
of state-wide, longitudinal data from the Florida Juvenile Justice Department (total N > 346,000 Black youths) to
(1) determine group trends and within-person changes in STBs and (2) identify how risk and protective factors
in different life domains intersect to increase and decrease the risk of STBs among JIBY. We will disaggregate
trends by age, gender, mental health, substance misuse, family environment, and other individual and
environmental factors. We also will identify within-person trends in STBs over time. Working from a concentrated
disadvantage framework, we will use higher-order interaction selection and classification to examine how risk
and protective factors across multiple domains influence risk of STBs. Further, we will (3) supplement these
quantitative analyses with qualitative interviews that center JIBY perspectives on risk and protective factors,
barriers they face in sharing and communicating STBs, and experiences with mental health services. Overall,
this project will provide novel insights into how suicide risk unfolds in the life context of JIBY and identify the
intersection of stressors in the family, school, neighborhood, and justice domains that influence STBs among
JIBY. Such insights will directly inform the development of culturally responsive suicide screening, prevention,
and intervention approaches for JIBY.

Public health relevance
PROJECT NARRATIVE There is an urgent need to identify risk and protective factors for suicide thoughts and behaviors (STBs) among Black youth. The proposed research directly addresses that need by examining theoretically- and culturally informed risk and protective factors for STBs in an especially vulnerable group: justice-involved Black youth (JIBY). Findings of the proposed research are expected to provide novel insights into how suicide risk unfolds in the life context of JIBY and identify the intersection of stressors in the family, school, neighborhood, and justice domains that influence STBs among JIBY.